Motherhood Biographies and Midlife Women's Health

Abstract
The Motherhood Biographies and Midlife Women’s Health R01 project maps how divergence in motherhood experi-
ences contributes to growing midlife health disparities. About 85 percent of midlife women today are mothers, but path-
ways to motherhood—what we call motherhood biographies—are increasingly diverse across many dimensions relevant
to health, including age at first birth and spacing of children. The parent project tests how motherhood biographies mat-
ter for midlife women’s health with a specific focus on race/ethnicity and socioeconomic status. We compare mothers
and non-mothers as well as mothers with differing motherhood biography profiles using nationally representative data
from the 1979-2018 waves of the National Longitudinal Study of Youth (NLSY79; N=4,951 women). We are testing the
following aims with this diversity supplement and Crutchfield’s efforts focused on Aims 2 and 3: AIM 1: Identify how
motherhood biographies—including childlessness—relate to midlife health. AIM 2: Identify how the impact of mother-
hood biographies on health depends on characteristics of child-mother relationship at midlife. AIM 3: Identify the heter-
ogeneous effects by educational attainment and race/ethnicity of motherhood biographies on midlife health. Given
Crutchfield’s research and career interests, the proposed supplemental project will be beneficial to all parties, as well as
to the broader field of health disparities research across the life course. Crutchfield will specifically look at two questions
that fall within the goals of the Parent R01’s Aims 2 and 3: (1) Do the dynamics/quality of mother-adult child relation-
ships at midlife shape the impact of motherhood biographies on health outcomes at the intersection of socioeconomic
status (SES) and race-ethnicity? and (2) Specifically among Black women, how does the impact of mother-adult child
relationship dynamics/quality at midlife on the association between motherhood biographies and health differ by SES?
Throughout the duration of the administrative supplement, which will be Crutchfield’s 4th and 5th years in the Doctoral
program, she will work with the entire team to obtain training specifically on aging and life course theories and meth-
ods;, take courses to advance her statistical training, especially related to longitudinal data analysis and causal inference
methods;, conduct research for publications, presentations, and other research activities public scholarship; and receive
career and professionalization training, including related to writing grants and applying for jobs in the aging and life
course field. Life course training will include rigorous training in an interdisciplinary Aging Certificate at Ohio State; sta-
tistical training will focus on course work on longitudinal data analysis and other life course methods. In addition, in Y2
of the grant (year 5 of her doctoral training), the entire mentorship team will also assist Crutchfield in developing an ag-
ing-related NIH F32 post-doctoral application for her post-doctoral training, which will facilitate Crutchfield’s eventual
goal to obtain a tenure-track position in an aging and health field. In doing so, this supplement is designed to improve
women’s health and reduce racial-ethnic health disparities in midlife and beyond, a key goal of NIA, while contributing to
the development of a minority junior scholar specifically in the area of aging.

Public health relevance
Project Narrative The parent research project and proposed supplement is highly relevant to public health in its ability to determine the role of motherhood biographies as a key mechanism in explaining racial-ethnic and socioeconomic health disparities among midlife women, particularly aging Black women. This proposed supplemental research will identify the most health-disadvantaged subpopulations of midlife mothers and nonmothers with attention to differences at the intersec- tion of race-ethnicity and socioeconomic status. In doing so, this R01 informs interventions and public policies designed to improve women’s health and reduce racial-ethnic health disparities in midlife and beyond, a key goal of NIA, while contributing to the development of a minority junior scholar specifically in the area of aging and life course research.